Functional Metagenomic Reprogramming of the Human Microbiome through Mobilome Eng

Project Summary The long-term goal of this research is to develop culture-independent strategies to effectively engineer and program the human microbiome in vivo. To this end, the objective of this proposal is to develop an enabling technology platform, named Genome Engineering by Self-Transmissible Replicons (GESTR), to allow the efficient delivery, propagation and expression of exogenous genes in the human microbiota, to characterize the kinetics of gene propagation in the microbiome, and to initially demonstrate the utility of such techniques in engineering the gut microbiota of mice. The specific goals of this work are i) to construct engineered self- transmitting conjugative transposons containing trackable payload genes and characterize their ability to mobilize into different strains typically found in the human gut microbiota; ii) to develop libraries of payload constructs to characterize transcriptional efficiency and codon adaptation for optimal payload gene expression in dominant gut microbes; and iii) to measure gene flow and transmission of exogenous genes by engineered self-mobilizable genetic elements in the gut microbiota of a murine model. Newly developed tools including Multiplex Automated Genome Engineering, de novo DNA-microarray-based gene synthesis, and meta- transcriptomics will be utilized to facilitate the development of this project. The proposed research will provide the first demonstration of key functionality and the development of sufficient new understanding to enable the broader use of this technology platform in future applications. Key questions in the dynamics of transmission and natural selection of laterally shared genes in the human microbiome will also be addressed. Engineering the human microbiome with augmented capabilities to report, prevent and reverse disease states and to modulate the metabolism of foods and drugs promises to be a critical avenue towards transforming human- associated microbes into micro-sensors, miniature protein-production factories, and adaptive bioremediation systems. This technology holds potential for development of clinical therapeutics of common microbial- associated diseases such as those of the gut (e.g. Crohn's, IBD, chronic maldigestion), oral cavity (e.g. dental caries), urogenital tract (e.g. infections, STDs), and skin (e.g. ectopic eczema).

Public health relevance
Project Narrative The proposed research project aims to develop foundational technologies to enable the genetic manipulation of microbes that are commonly associated with the human body. These endeavors will facilitate the development of preventative measures and therapeutics to combat microbial-associated human diseases including those of the gut, mouth, nose, skin, and urogenital organs. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS The long-term goal of this research is to develop safe culture-independent strategies to effectively engineer and program the human microbiome in vivo. To this end, the objective of this proposal is to develop an enabling technology platform to allow efficient delivery, propagation and expression of exogenous genes in the human microbiota, to characterize the kinetics of gene propagation in the microbiome, and to demonstrate the utility of such techniques by engineering the gut microbiota of mice. Engineering the human microbiome with augmented capabilities to report, prevent and reverse disease states and to modulate the metabolism of foods and drugs promises to be a critical avenue towards new therapeutics to enhance human health. While advances in high-throughput sequencing have enabled us to profile the human-associated microbiota under healthy and disease states1, our ability to engineer these microbial members has lagged far behind. Current microbial engineering methods still rely on decade-old recombinant technologies using individual culturable model organisms that cannot be scaled to complex microbial consortia like those found in the gut, where 80-90% of the microbes have not been cultured2. Strategies using probiotic supplementation to alter the native microbiome have been generally met with failure because probiotic strains cannot effectively compete with the native residents and are not retained in the microbiome long-term. Here, we hypothesize that the human microbiome can be effectively manipulated through engineering the mobilome, the set of mobile genetic elements (MGE) that permeate the microbiome, and that genes and traits introduced through the mobilome are more likely to be retained within the microbiome over time when compared with traditional probiotic strategies. To test our hypothesis, we propose the following Specific Aims: Aim 1: To construct engineered self-transmitting conjugative transposons containing trackable payload genes and characterize their ability to mobilize into different strains typically found in the gut microbiota. We envision a general delivery system that can infiltrate the native microbiome, deliver a payload of engineered genetic elements, and ensure that those genes are maintained in the microbiome. Using our Multiplex Automated Genome Engineering (MAGE) platform developed previously, we will construct and characterize a library of a self-replicative transposable elements and broad-host range vectors in both gram- positive and negative bacteria of the gut microbiome in vitro. This system, called Genomic Engineering by Self- Transmissible Replicons (GESTR), will be characterized in 10 representative members of the human gut microbiota. We expect this aim to generate GESTR vector designs that can propagate from the E. coli donor to one or more of the tested recipients at higher than background levels (e.g. >10-9 per recipient). Furthermore, we will map out the lateral gene mobilization rate of designed GESTR vectors in our in vitro cultures. Aim 2: To develop and characterize libraries of payload constructs for optimal payload gene expression in dominant gut microbes using de novo gene synthesis and multiplexed genome engineering. We propose to determine the optimal profiles for heterologous gene expression of abundant and relevant gut microbes using a library of 2 million transcriptionally-varying and codon-adapted reporter constructs. Understanding key determinants that govern expression of horizontally transferred genes has relevance towards understanding the constraints for disseminating commonly shared genes include those causing antibiotic resistance and pathogenicity in the human gut microbiota. Through this aim, we expect to generate optimal expression and codon-usage parameters for each of 10 representative members of the gut microbiome to enable efficient expression of heterologous genes for genetic augmentation. Aim 3: To characterize gene flow in a complex microbial consortium and demonstrate transmission of exogenous genes by GESTR in an in vitro and in vivo murine model. We propose to characterize the ability of GESTR to mobilize across a synthetic microbial community both in an in vitro solid-surface culturing model and in vivo in a gnotobiotic mice model. Following inoculation on solid agar plates and into gnotobiotic mice using a defined microbial community of 10 members, we will temporally monitor the abundance levels of the synthetic consortium and the mobilized exogenous payload constructs using quantitative PCR, genetic selection, microscopy, cell sorting, and sequencing. Through this aim, we expect to have characterized the dynamics of horizontal gene transfer in a defined microbial consortium and provided the first successful demonstration of GESTR to penetrate, deliver, and propagate synthetic genes in the gut of living mice. Summary of Expected Outcomes. We expect to have demonstrated a new technology platform that enables the engineering of microbial consortia in their native environment through the manipulation and augmentation of the mobilome. We expect to have demonstrated functionality of key elements and developed sufficient new understanding to facilitate the broader use of this technology platform in future applications to enhance public health efforts to combat diseases associated with the human microbiome in a safe and responsible manner.